Development of nitroreductase-activated inhibitors to treat mycobacterial infections

Tarn Biosciences, Inc. (Tarn) is discovering and bringing to market novel drugs for the treatment of
mycobacterial infections, including both drug-susceptible and drug-resistant (DR) tuberculosis (TB) and non-
tuberculous mycobacterial (NTM) infections. TB is caused by the bacterium Mycobacterium tuberculosis (Mtb)
and NTM infections are caused by diverse mycobacterial species, including M. abscessus (Mab). TB is the
greatest bacterial killer in the world while NTM is a serious and growing problem worldwide, including in
developed nations. Both TB and NTM are primarily pulmonary infections that cause chronic, debilitating, and
deadly disease. The goal of this STTR is to develop the novel nitroreductase-dependent inhibitors, the parent
compound HC2210, as new treatments for TB and NTM infections.
With the recent approval of pretomanid and delamanid for TB treatment, nitroreductase-dependent
compounds have emerged as important agents to control TB. Pretomanid and delamanid kill Mtb by targeting
essential cellular processes , including respiration or cell wall biogenesis, and are effective against nonreplicating
Mtb. Notably, pretomanid and delamanid are not active against Mab and the pharmacokinetics (PK) profile and
side effects of the compounds reduce their clinical utility for certain TB patients. Due to these challenges, there
is an unmet need to develop new antimycobacterial nitroreductase-dependent compounds with improved
therapeutic utility and activity against NTMs.
We discovered a new series of nitrofurans, represented by HC2210, that are potent inhibitors of both Mtb
and Mab. HC2210 is >20-fold more potent than pretomanid, with a 30 nM half-maximal effective concentration
against Mtb. When HC2210 was administered orally in a chronic murine model of TB infection, it reduced Mtb
burden by >10-fold in the lungs and spleens of infected mice. These proof-of-concept data show HC2210 is
orally bioavailable, tolerable and efficacious in a chronic mouse model of Mtb infection, reaching a critical
milestone in the development of a new antimicrobial.
The product of this proposal is H2210 analogs. HC2210 has favorable drug-like properties, and is potent
and orally efficacious in animal models. Michigan State University holds patent applications for the use of
HC2210 to treat TB and NTM infection and composition of chemical matter for HC2210 and related analogs.
MSU is in licensing negotiations with Tarn Biosciences to purse further development of the series. The goal of
this Phase I project is to optimize and prioritize three HC2210 analogs with favorable in vitro and in vivo drug-
like properties and demonstrate efficacy in chronic murine models of Mtb and Mab infection.

Public health relevance
PROJECT NARRATIVE The spread of tuberculosis is a global health crisis leading to over one million deaths annually. The global burden of tuberculosis is a threat to the health of all Americans, and directly relevant to the mission of the National Institute of Allergy and Infectious Diseases, given the easy transmission of the disease through the air and the emergence of drug resistant strains that are difficult to treat. Infections with non-tuberculous mycobacterial infections are also a serious problem in the United States, particularly in individuals with underlying conditions such as Cystic Fibrosis or chronic obstructive pulmonary disease.